Mechanistic Characterization of the Replication Stress Response

PROJECT SUMMARY
Accurate DNA replication is a fundamental process that governs the survival of every organism.
Cellular DNA is under constant assault from various sources. The cellular replication machinery
frequently encounters and is severely vulnerable to agents that stall its advancement, leading to
replicative errors, development of mutations, and various forms of genetic instability. As a result
of this, elevated levels of replication stress is a characteristic hallmark of various disease
conditions. It is therefore critical to understand in molecular detail the varied mechanisms by
which cells respond to and adequately repair damaged DNA during replication stress. Although
we know a lot about how breaks in DNA are repaired, there is a major gap in our understanding
of how cells adequately respond to replication stress in part due to the lack of genetic and
biochemical tools to probe these processes. To gain further insights into the processes involved
in the replication stress response, and in order to identify and characterize the panoply of genes
required for this pathway, during my postdoc I performed whole genome screens in multiple cell
lines following perturbations with low doses of replication stress-inducing agents. From these
screens I generated a novel dataset that includes multiple genes that have yet to be linked with
genome instability. Several newly identified genes were linked to chromatin responses,
replication fork maintenance pathways, regulation of nucleotide biosynthesis and others. Of
note, I identified the Protexin complex, consisting of the single stranded DNA binding protein
SCAI and the DNA polymerase REV3. Protexin was critical for maintaining genomic instability
by regulating single stranded DNA accumulation through unknown mechanisms. These screens
also revealed a striking role for RNA dependent processes in the replication stress response, a
novel layer of regulation that had not been appreciated before now. Among our top hits, we
identified several novel RNA helicases and RNA-binding factors, as well as several non-coding
RNA molecules, demonstrating a crucial, intimate link between RNA-dependent processes and
adequate maintenance of genome stability. My lab will take advantage of this vast resource of
newly identified factors to characterize novel genome maintenance mechanisms. Investigating
these novel factors will allow us to decipher in detail the concerted, multi-layered repair
response and fork restoration control upon exposure to DNA damage. We will (1) characterize
the mechanism of single stranded accumulation following replication stress. 2) Identify
mechanisms by which RNA-modifying enzymes function in the replication stress response, and
3) elucidate roles for non-coding RNA genes during the replication stress Response.
Completion of these research projects will grant us significant and fundamental novel insights
into how cellular genomes are maintained in the face of damaging insults, grant us improved
mechanistic understanding of the principles of cancer pathogenesis in greater detail and open
up novel avenues for exploiting defective DNA repair processes in the treatment of cancers.

Public health relevance
PROJECT NARRATIVE Genomic instability is a hallmark of many disease conditions, including cancers, and is often caused by replication defects. Our work aims understand in greater detail the varied mechanisms by which cells respond to replication stress by studying the interplay between RNA dependent processes and DNA replication integrity. Adequately understanding these processes will improve our understanding of the molecular underpinnings of genome maintenance and provide critical novel insights that can be exploited in novel therapeutic approaches.